CHEMICAL ABSTRACTS SERVICE - CLIENT SERVICES

The Contractor shall provide all the required services, qualified personnel, materials, equipment, and facilities not otherwise provided by the Government to perform CAS Registry Services, CHEMLINE Support, and Contract Administration.